Cell lineage and transcriptional analysis of the vertebrate neural plate border

Bronner, M.E.
In the early embryo, the neural plate border region contributes to diverse cell fates, ranging from neural
crest cells and ectodermal placode cells to neurons of the central nervous system. Despite extensive studies of
the neural crest and ectodermal placodes at post-neurula stages, surprisingly little is known about how these
populations become distinct from one another within the early neural plate border. Based on our preliminary
data, we hypothesize that many neural plate border cells are multipotent as evidenced by their
concomitant expression of markers characteristic of several fates. We will test this hypothesis by: 1)
conducting a detailed analysis of the emerging neural plate border region by multiplex protein and gene
expression profiling coupled with cell lineage analysis and 2) examining how perturbation of transcription factor
levels affects expression profiles and lineage allocations of individual neural plate border cells. The significance
of this proposal is that it will be the first to test how and when ectodermal placode precursors are segregated
from neural crest and neural precursors at the neural plate border. The following aims will be performed:
Aim 1: High resolution analysis of protein expression of neural plate, neural crest, placode and other
ectodermal markers in the neural plate border as a function of time. We will examine co-expression of
transcription factors associated with neural crest, placode, neural plate and ectodermal lineages
quantitatively and at single cell resolution in chick gastrula to neurula stages to determine their degree of
overlap and if/when a discrete separation occurs between them in the neural plate border. To take this to a
multiplex level, we will then perform single molecule fluorescent in situ hybridization analysis (smFISH) at
similar stages with 35 or more probes selected from known genes and new candidates from our single cell
RNA-seq dataset.
Aim 2: Molecular dissection of regulatory interactions that mediate gene expression and cell fate
choice at the neural plate border. We will examine the consequence of perturbing individual transcription
factors (e.g. Pax7, Sox2, Six1) on expression of others neural plate border genes at the population and
single cell level. To examine inputs that regulate neural plate border formation, we will dissect novel
enhancers for Pax7, Six1 and other genes to determine direct regulatory inputs. Finally, we will examine
how balancing levels of transcription factors may influence other factors in the neural plate border region.
Aim 3: Single cell lineage analysis of cells at the neural plate border. To definitively test whether
individual cells at the neural plate border have restricted or broad developmental potential, we will carry out
single cell lineage analysis by performing iontophoretic injection of lysinated rhodamine dextran into
individual neural plate border cells. We also will use enhancers for Pax7, Sox2, or Six1 as well as
photoconversion of individual cells to follow the long term fate of neural plate border cells and examine how
blocking individual transcription factors affects cell lineage allocation.
1

Public health relevance
Public Health Relevance Statement Neural crest and ectodermal placode cells are both transient embryonic progenitor cells that arise from the neural plate border. They then either invaginate or undergo an epithelial to mesenchymal transition, undergo reshaping or migration and differentiate into various derivatives ranging from ganglia and sensory organs of the peripheral nervous system to (in the case of neural crest) bone and cartilage of the face, cornea of the eye to pigmentation of the body. About 10% of human birth defects, such as CHARGE or DiGeorge syndromes or Hirschprung's disease, affect early neural crest or placode development. However, the molecular mechanisms underlying these defects are largely unknown. Several cancers also originate from the neural crest including the peripheral nervous system derived neuroblastoma, the most common malignancy of infancy, as well as melanoma, pheocromocytoma and other endocrine tumor types. The proposed experiments promise to illuminate the molecular and cellular processes that result in early formation of neural crest and ectodermal placode cells and their derivatives. The results of this study may inform upon diagnosis, therapeutic intervention and also yield approaches guiding maintenance of neural crest and placodal stem cells for the purpose of repair and regeneration. .